A microED pipeline for the pharmaceutical and biotechnology industry

Project Summary/Abstract
Microcrystal electron diffraction (microED) is an emerging structure determination technique of high interest to
the pharmaceutical and biotechnology industries. MicroED can rapidly determine atomic-resolution structures
from microcrystals with minimal sample requirements. The goal of this Phase II proposal is to develop and deliver
robust service offerings for microED structure determination to the commercial sector. Improvements to critical
steps in this workflow will enable analysis for any suitable sample type while offering a level of efficiency that
meets the requirements of Structure-Based Drug Design (SBDD) and medicinal chemistry programs. The
permissive sample requirements, minimal time requirements, and high-quality structures generated make
microED an attractive structure determination technique with broad applications for small molecules, peptides,
natural products, proteins and protein-drug complexes. An efficient microED pipeline will help to reduce the cost
of drug development and reduce the time it takes a drug to make it into the clinic.
MicroED uses a transmission electron microscope (TEM) to collect diffraction data from small crystalline
samples. The steps required include transferring crystalline samples to TEM grids; collecting a series of
continuous-rotation, electron-diffraction datasets from single crystals; processing the diffraction data and refining
the atomic model. An initial development phase demonstrated collection of excellent quality diffraction datasets
for more than 20 samples, and the ability to deliver atomic resolution maps suitable for addressing the needs of
our pharmaceutical clients who took part in alpha and beta testing. New methods will be developed, and existing
approaches optimized to improve every step of this pipeline, substantially increase throughput, and improve final
maps and models. Specific aims include: (1) Optimizing TEM grid preparation to ensure the transfer of a sufficient
number of high-quality target microcrystals onto the grid substrate without damaging them or altering their
properties. (2) Developing an automated, high-throughput data collection system capable of unattended,
overnight data acquisition for multiple different samples, and of providing information to inform data scaling and
determining handedness of chiral small molecules. (3) Automating and improving data processing, phasing and
model refinement including real-time data reduction, brute force on-the-fly phasing, and investigating a wide
range of new programs and methods.
In parallel with the Phase II research plan, a full commercial service offering spanning the complete range of
microED capabilities will be developed.

Public health relevance
Narrative High-resolution structures of proteins, small molecules and their complexes are a critical part of the drug discovery process collectively known as Structure-Based Drug Design (SBDD) in the pharmaceutical and biotechnology industries. MicroED is an emerging structural technique that will support advancement of human health through enabling novel molecular targets for chemotherapies and new biologics. NanoImaging Services (NIS) proposes to build upon an initial microED service offering to deliver an expanded suite of services aligned with the unique needs of the industrial market, addressing reproducibility, throughput, affordability, speed, and flexibility.